Administrative Supplement: CSRN Vanguard Study

PROJECT SUMMARY/ABSTRACT
This application is being submitted in response to the NOSI identified as NOT-CA-24-111. Although evidence-
based cancer screening protocols exist for several common cancer types, an estimated 70% of cancer deaths
are due to cancers for which no early detection test is yet available. Multi-cancer detection tests (MCDs) seek
to fill this gap using advances in cell-free DNA detection to identify multiple cancer types from a single blood
draw. This new approach to cancer screening has the potential to revolutionize early detection and reduce
cancer mortality. MCDs are rapidly moving toward general commercial availability, and studies in diverse
populations are urgently needed to improve our understanding of the risks and benefits associated with these
tests and how best to implement them appropriately and effectively. To address these gaps the National
Cancer Institute created the Cancer Screening Research Network (CSRN) to evaluate novel screening
technologies with the first objective being to understand the feasibility of a randomized control trial for MCDs.
To do so, the CSRN will implement the Vanguard feasibility study. The University of North Carolina Lineberger
Comprehensive Cancer Center is one of 9 CSRN ACCESS (Accrual, Enrollment, and Screening Sites) Hubs.
To increase the likelihood of successfully enrolling 2000 patients from the NC ACESS Hub onto the Vanguard
Study, including recruiting diverse and historically underrepresented populations from UNC Health, our
statewide health system, and participating Federally Qualified Health Centers (FQHCs), additional funds are
needed beyond what was requested in the parent grant. Our overarching aim is to accelerate research on
emerging cancer screening technologies in partnership with the CSRN. In this administrative supplement
application, we propose to (1) support enrollment goals and recruitment of a diverse patient population by
hiring additional clinical research staff dedicated to Vanguard Study recruitment and enrollment ; (2) hiring and
deploying a clinical trials patient navigator who will provide clinical trial education and enrollment support at
institutional and community partner site location distal to the main campus NC Hub. This navigator will connect
patients underrepresented in clinical trials with providers and clinical trial opportunities, as well as act as a
navigator for enrolled Vanguard Study patients who receive a positive MCD test to ensure timely workup and
diagnostic resolution; (3) cover the cost of the initial diagnostic work-up and any associated travel costs for
patients who receive a positive MCD test; and (4) implement biospecimen workflow support with the central
UNC laboratory to insure specimen integrity. These additions to our NC ACCESS Hub team, and the ancillary
resources provided to participants will support the critical CSRN goal of recruiting a diverse screening eligible
population representative of the racial, ethnic, and rural/urban distribution of both NC and the US. As part of
the CSRN, the NC ACCESS Hub is excited to significantly contribute to the rapid evaluation of emerging
cancer screening technologies and future studies of MCDs, but recognizes the challenges associated with
recruitment, retention and support of diverse populations, thus requests supplemental funding for high yield
interventions that will serve to promote collection of high-quality evidence to inform the use of these tests in
clinical practice across diverse US populations.

Public health relevance
PROJECT NARRATIVE As one of the 9 CSRN ACCESS Hubs, we propose to leverage our cumulative expertise in cancer screening and the resources of the University of North Carolina, UNC Lineberger, UNC Health, and Federally Qualified Health Centers (FQHCs) to successfully enroll 2,000 patients onto the Vanguard Study. Our catchment area serves the entire state of North Carolina, offering a patient population that spans urban and rural locations, varied socioeconomic levels, and racial and ethnic diversity similar to the southeastern US population. To significantly contribute to the evaluation of multi-cancer detection (MCD) screening that will inform future studies, supplemental funds are requested to promote collection of high-quality evidence to inform the use of these tests in clinical practice across diverse US populations. Project Narrative Page 7